Pacific Northwest Center for Translational Health Research Admin supplement

OVERALL SUMMARY
The Pacific Northwest Center for Translational Environmental Health Research (PNW EHSC) has been
instrumental in leading, growing and enhancing collaborative translational environmental health science (EHS)
research in the Pacific Northwest region for over 40 years. As its lead institution, Oregon State University
(OSU) has capacity for PNW EHSC members and partners to make deep inquiries spanning the spectrum of
exposure biology using synergistic cutting-edge technologies and expertise. The strategic vision of the PNW
EHSC is and has been to facilitate innovative and engaged research to improve environmental public health,
reduce risks of exposure, and advance co-development of knowledge of interactions between environmental
factors and human biology. The specific aims of the PNW EHSC are to 1) Advance environmental health
science, 2) Promote the translation of data to knowledge to action, and 3) Enhance environmental health
science through stewardship and support. The Administrative Core (AC) will continue to provide crucial
leadership through the Executive Leadership Team, including career development opportunities for Center
members. The Integrated Health Sciences Facility Core (IHSFC) and the Community Engagement Core (CEC)
will continue active collaboration to facilitate and maintain multi-directional connections and communications
among Center members and partners. The IHSFC will continue to accelerate collaborations among Center
members to address environmental health questions and provide technical support across a range of needs
including human subjects research, biospecimen collection and handling, biostatistics, and bioinformatics. The
CEC will remain committed to advancing research translation across Cores and building best practices in
community engagement practice, science communication, and evaluation science to support EHS research
needs. The incredibly innovative and synergistic Facility Cores will continue with support of transformative and
translational interdisciplinary research. The Chemical Exposure Core (CXC) enables minimally invasive and
relatively low-cost identification of over 1,500 individual chemicals through various passive sampling devices.
The Zebrafish Biomedical Research Core (ZBR) is capable of developing transgenic and gene-edited zebrafish
lines and other customizable assays to provide deep dives into mechanistic toxicology. The CXC and ZBR will
continue to enable a full spectrum of exposure biology services and when combined with the leadership of the
AC, the translational support available through the IHSFC, and the best practices developed and implemented
by the CEC for engaged research, EHS research in the region will continue to accelerate and generate impact
due to the benefits of having an operational PNW EHSC.

Public health relevance
PROJECT NARRATIVE The Oregon State University Pacific Northwest Center for Translational Environmental Health Science Research (PNW EHSC) will continue to support Center researcher and partner engagement capacity to help understand what people are exposed to in their homes, at their work places, and in their communities, and to discover what hazards these exposures may pose to their health. The PNW EHSC will remain steadfast in its aims to address environmental health concerns of individuals, communities, industries, and regulators to better protect and improve environmental public health.